Animal Models Module

Animal Models Module
Abstract
The objective of the Animal Models Module is to enhance the capabilities of individual investigators to conduct
cutting edge research in the vision sciences, which involves studying normal function of the visual system and
generation and characterization of animal models of disease. Our Aims are: 1) to provide resources, support
and training required for conducting animal studies at the level exceeding the capabilities of any individual
laboratory; 2) to promote collegiality across the community of vision scientists through sharing resources,
techniques and expertise; and 3) to engage colleagues into conducting vision research, including support of
the next generation of basic and clinician scientists. To achieve these Aims, this Module will support
sophisticated facilities equipped with state-of-the-art instrumentation, including surgical equipment and
instrumentation for morphological, functional and behavioral analyses of animal eyes and visual performance.
The Module is supervised and operated by highly experienced personnel, with expertise in conducting a broad
array of animal studies and deep understanding of associated regulatory conditions. These shared resources
will open new research possibilities for both experienced and novice users, and will serve as a platform for
fostering interactions among a broad swath of our research community.